Pelvic Floor Disorders Network Data Coordinating Center

Project Summary
RTI International proposes to continue to serve as the data coordinating center (DCC) for the NICHD Pelvic
Floor Disorders Network (PFDN) in support of its mission to improve the care of women with pelvic floor
disorders (PFDs) by conducting well-designed multicenter observational studies and clinical trials to inform
diagnosis, prevention, and treatment. Building on 10 years of experience as PFDN DCC, RTI will provide the
Network with statistical leadership in study design and data analysis and operational support through data
management and logistical services. Specifically, the DCC will (1) lead innovative study designs and analyses
to address challenges specific to PFD research, including bench-to-bedside translational studies, by providing
expertise in biostatistics, statistical genetics, psychometrics, health economics, machine learning, and other
fields and collaborating with clinical investigators to develop rigorously designed studies with outcome
measures important to women with PFDs; (2) provide tools for communication and collaboration to facilitate
rapid development of protocols and web-based systems for electronic data capture (including direct capture of
patient-reported outcomes via mobile applications), biospecimen tracking, omics data pipelines, and training;
(3) conduct data management, quality assurance, and monitoring procedures throughout the life of each study,
capitalizing on centralized and remote monitoring capabilities for efficient use of network resources; (4) report
on data quality, protocol adherence, and safety, and perform statistical analysis for presentation at national and
international conferences, and publication in top-tiered journals; and (5) coordinate remote and in-person
meetings, manage subcontracts, provide automatic capitation payments to sites, and manage biospecimen
transport and storage, study drug acquisition, and equipment and supplies distribution as needed to support
network studies. Dr. Marie Gantz as DCC Principal Investigator (PI) and Dr. Sonia Thomas as Alternate PI will
provide continuity of proven DCC leadership into the next PFDN cycle. They are supported by a team with
extensive PFD research experience, with flexibility to adjust staffing and bring in additional expertise as
needed to support the evolving needs of the PFDN.

Public health relevance
Project Narrative The PFDN was established in 2001 to improve the care of women with PFDs by conducting well-designed multicenter studies to inform diagnosis, prevention, and treatment. A qualified, experienced DCC is critical in helping the PFDN optimize research productivity through effective study design, implementation, data collection, quality assurance, monitoring, and statistical analysis. RTI will continue to provide multidisciplinary expertise to support high-impact collaborative clinical research studies and provide communications and logistical support to optimize the efficiency and productivity of the Network.